IMSD at Emory University

PROJECT SUMMARY/ABSTRACT
This is a new Initiative for Maximizing Student Development (IMSD) T32 application to support graduate training
at Emory University. The proposed training leverages activities that support an established IMSD combined
graduate/undergraduate program but adds innovative components focused on successful graduate training to
achieve the goal of developing a diverse pool of scientists earning a PhD, who have the skills to successfully
transition into careers in the biomedical research workforce. Graduate training opportunities at Emory include a
broad array of biomedical, public health, computational and other STEM disciplines. This breadth is achieved
through interdisciplinary research training in one of many possible graduate programs within the Laney Graduate
School (LGS). An interdisciplinary academic culture and environment coupled with extensive expertise in STEM
research makes Emory a fertile environment for training the next generation of scientific leaders. This ambitious
proposed T32 will support students during Year 1 and 2 of training in one of 17-participating graduate programs
that span a set of eight (8) interdisciplinary graduate programs in the Graduate Division of Biological and
Biomedical Sciences (GDBBS), six (6) programs in the Rollins School of Public Health (RSPH), two (2) programs
in Emory College of Arts and Sciences (ECAS), and one (1) in concert with the Emory School of Medicine (SOM).
IMSD activities are designed to complement program-specific activities to avoid increased demand on IMSD
T32-supported students. The primary activity supporting the proposed IMSD training is a one-credit Professional
Development Seminar, which strives to build an inclusive community that bolsters scientific identity, provides
skills-based learning to supplement discipline-based training, and provides access to professional development
and networking opportunities. Other IMSD training activities include a pre-enrollment orientation session and
requirements for both quantitative and scientific writing courses during the two years of T32 support, with
continued engagement throughout graduate training via annual check-in meetings with IMSD leadership and a
yearly IMSD retreat and symposium. Innovative aspects of the program include an MPI leadership team that
brings distinct skills to student training while also providing representation of the different invested Emory units
(ECAS, RSPH, SOM) as well as leadership demonstrating the commitment of the graduate school in dedicated
effort from the Associate Dean for Diversity, Inclusion, and Community Engagement. A full-time IMSD Assistant
Director brings key experience, including a PhD in STEM and formal training in STEM education, to the
leadership. This structure allows individualized attention to the success and wellbeing of students as they
matriculate through graduate training and chart their path to the PhD. Furthermore, the T32 mandates annual
mentor training for ALL faculty advisors to build an inclusive research environment. The depth of the pool of
admitted students who would be eligible for this T32 combined with the track record of training and the potential
for further enhanced impact within Emory provides a strong rationale for this proposed training program.

Public health relevance
PROJECT NARRATIVE This new application requests funding to support an Initiative for Maximizing Student Development (IMSD) T32 at Emory University that will support graduate students from groups historically excluded and underrepresented in biomedical science at an early stage of graduate training to position them for success. We propose activities to support graduate training by building scientific identity and resilience while embracing research excellence through an engaged, supportive, and diverse IMSD community. Training activities, which will complement but not duplicate, discipline-specific requirements will: include evidence-based learning approaches, train students in scientific writing through a formal course, ensure training in rigor and reproducibility, mandate mentor training for all faculty mentors, build mentoring and professional networks, and emphasize career/professional development with the goal of contributing to student success and a diverse biomedical research workforce.